Core--Histology

The Histology Core is responsible for overseeing all histological procedures used in this Program Project Grant, including trouble-shooting immunohistochemical and in situ hybridization procedures in conjunction with personnel from the individual projects. A full-time Research Technician and a supervising Research Analyst (whose salary is provided by the Department of Cell and Molecular Physiology) will conduct many of the procedures listed in this proposal; they will be assisted by research staff from several projects within this application with other protocols. Alan R. Light will be as an advisor to the core. The Histology Facility has been responsible for a number of techniques that have allowed more efficient use of histological methods on Principal Investigators' past projects in a Program Project Grant, previously led by Edward R. Perl. The Histology core occupies 600 ft/2 in an area on the ground floor of the Department of Cell & Molecular Physiology, and it is easily accessible for Projects 1 and 3. This facility houses all the major equipment necessary for the histological procedures described in the projects.